DIDR-Dissemination & Implementation in Diabetes Research

PROJECT SUMMARY/ABSTRACT - Dissemination and Implementation in Diabetes Research Core
The primary goal of the Dissemination and Implementation in Diabetes Research Core (DIDR) is to assist
Washington University Center for Diabetes Translation Research (WU-CDTR) investigators in filling the gap
between discovery of new knowledge generated by their diabetes research and the equitable application of this
science to ultimately inform and benefit patient and population health. The DIDR Core has been critical in
expanding the cadre of investigators conducting translational research in diabetes and building novel
partnerships. Over the past five years, the Core has contributed to the evolving research methods that support
high quality dissemination and implementation (D&I) studies including innovative research designs, novel D&I
strategies, specialized measures assessing current research and practice related to D&I in diabetes
interventions, and methods to understand context and tap stakeholder preferences. Additionally, D&I methods
support research conducted within clinical and community settings that represent real-world practice, which
necessitates specialized methods to fit research within the normal operating procedures of practitioners and
organizations.
The DIDR Core actively supports WU-CDTR investigators by providing expertise and resources in D&I
science to advance health equity. The Core also supports clinical and academic partnerships and those that
extend to community contexts and non-healthcare sector organizations with missions that directly address social
determinants of health and reach populations that can most benefit from effective interventions and
approaches for diabetes prevention and management. Current DIDR Core services build on this experience in
implementing DIDR activities and supporting the large number of investigators pursuing D&I research. Based
on this successful history, promising trajectory, and systematic core evaluation, we expect continued growth of
DIDR services to support D&I research of WU-CDTR investigators.
The specific aims of the DIDR Core are to: (1) accelerate the application of advanced methods in D&I
science by providing one-on-one consultative services for diabetes translation research; (2) enhance the impact
of web-based D&I tools and resources by providing technical assistance; and (3) build team capacity in the skills
essential for D&I of diabetes translation research.
The DIDR will continue to lead in D&I science and foster this vibrant and growing community of WU-
CDTR investigators conducting transformative D&I research to help ensure interventions are designed for
dissemination, implementation, and sustainability to promote rapid translation from research to practice.